The flavin-centric metabolic lifestyle of Treponema pallidum

Project Summary/Abstract
Despite its historical importance as a plague on humankind, syphilis remains among the most poorly
understood of all human infections. This is a direct result of severe research constraints imposed by the
historic inability to cultivate Treponema pallidum (Tp) continuously in vitro. In a departure from more
conventional approaches, about 15 years ago we embarked on a bold structural biology-based initiative to
characterize Tp’s lipoproteins (LPs), molecules critical to the membrane biology, bioenergetics, and
intermediary metabolism of Tp, as a means of unlocking the mechanistic evolutionary “secrets” of Tp
infection and syphilis pathogenesis. This progressive research avenue has become a very successful
discovery platform, yielding many highly novel findings, including establishing a number of new bacterial
molecular paradigms. For example, we discovered a novel bi-functional FAD pyrophosphatase/FMN
transferase in Tp; this, in turn, led us to identify a post-translational protein flavinylation pathway in Tp’s
periplasm, yielding flavoproteins that ostensibly influence cellular redox reactions. We then obtained
evidence for Tp encoding an atypical flavin-based Rhodobacter Nitrogen Fixation (RNF)-type redox pump,
likely representing the longstanding missing link between Tp’s membrane electrochemical gradient, redox
balance, ATP generation, and an acetogenic energy conservation pathway. Historically, Tp has been
thought not to encode such systems. Our contention of a flavin-based redox system not only addresses a
number of longstanding unexplained metabolic dilemmas for Tp, but it also engenders a paradigm shift by
now establishing Tp as a flavin auxotroph. We also have demonstrated that TP0572, a putative FMN-
dependent ferric reductase, is flavinylated by Ftp (TP0796), likely an essential prerequisite for Tp’s
reductive iron assimilation pathway(s). In addition, predicted cytosolic flavoproteins must play prominently
in protecting Tp from oxidative stress and in maintaining the balance of NAD+/NADH. These collective
notions support that, with limited potential for ATP generation in the absence of quinones, Tp has evolved
a “flavin-centric metabolic lifestyle” to fulfill its metabolic requirements for human infection. This project
shall address three core metabolic features relevant to Tp’s flavin biology: protein flavinylation and
flavoprotein biogenesis (Aim 1), reductive iron assimilation and Fe-S protein biogenesis (Aim 2), and redox
balance/energy conservation (via acetogenesis) (Aim 3). We also shall evaluate a small-molecule
inhibitor(s) targeting Tp’s flavin auxotrophy as a potential new research tool(s) and/or new
antimicrobial(s) against Tp and other pathogenic spirochetes (Aim 4). Taken together, this project shall
elucidate key features concerning how Tp has evolved to exploit flavins as an underpinning of its stealth
pathogenicity, potentially leading to new strategies to thwart human infection.

Public health relevance
Project Narrative Syphilis, caused by the bacterium Treponema pallidum, continues to play prominently as a sexually transmitted infection in the United States and worldwide. Given that the membrane lipoproteins of T. pallidum are recognized as being particularly vital to the biology of the spirochete, we are attempting to discern how the lipoproteins and their metabolic partners play prominently in T. pallidum’s complex parasitic strategy, with an emphasis on flavin utilization, thereby potentially revealing new strategies to thwart the infectious process in humans.